Integrated Virginia Research Training Centers in KUH (IGNITE KUH)

Center for Survey Research (CSR). Originally, we sought assistance from the CSR to assess the efficacy of the training program to conduct a mixed-mode, multi-phase program evaluation across three key stakeholder groups: (a) predoctoral and postdoctoral trainees; (b) faculty mentor; and (c) prospective trainees. Support was requested for Kara Fitzgibbon, PhD, Director, Center for Survey Research, Weldon Cooper Center for Public Service, UVA, and her team. For Year 1 we will assume more of this responsibility internally. Funds for this activity will be requested for subsequent out years.
Most of the reductions were staff and key personnel support. We will continue to
achieve the aims of the proposal with assistance from our respective institutions.
We do not anticipate other changes.

Public health relevance
NARRATIVE Despite the increase in disease burden in the areas of kidney, urology and hematology, there is a shortage of workforce to advance scientific discoveries and technology for all Americans. The Commonwealth of Virginia is home to 3 major centers for biomedical research, but they remain somewhat isolated due to distance between institutions. Furthermore, undergraduate students in the Commonwealth that are underrepresented in science may not have adequate access or exposure to KUH training opportunities. The Integrated Virginia Research Training Centers in Kidney, Urology and Hematology (IGNITE KUH) was designed to address these limitations by developing a collaborative and integrated partnership involving three major research training centers in the Commonwealth of Virginia that are committed to developing the next generation of diverse KUH researchers.